Continuous in vitro culture and genetics of Plasmodium vivax in a bespoke blood cell bioreactor

Project Summary
Malaria resulting from infection of humans with the parasite Plasmodium vivax parasite remains a significant
public health problem. Significant gaps remain in our understanding of P. vivax blood- and transmission-stage
biology, as well as the development of drug and vaccine interventions. When compared to that of Plasmodium
falciparum, this knowledge lags substantially because of the lack of an in vitro culture system. Indeed, much of
our undersatnding of P. vivax is based on limited studies in human and animal model systems. We hypothesize
that mimicking physiologically-relevant conditions experienced by P. vivax will support continuous culture in
reticulocytes, the youngest of red blood cells and the host cell of the parasite.
Our long-term objective is to continuously culture P. vivax parasites. We will utilize a bioreactor to control the
culture environment to facilitate P. vivax growth in in vivo-like conditions, including in co-cultures with stromal
cells from the bone marrow and splenic niches. In parallel, we will draw upon our expertise in in vitro genetics
for both RBCs in vitro and Plasmodium parasites: we will engineer stem cells capable of producing reticulocytes
more susceptible to P. vivax infection and recombinant parasites with enhanced ability to invade red blood cells.
We thus will focus on optimizing parasite and reticulocyte health, as well as host-parasite interactions.
Our specific aims in the R61 period are to optimize P. vivax culture in a bespoke bioreactor wherein we will mimic
the in vivo physiological conditions of parasite proliferates. This includes: (1) the efficientproduction of host
reticulocytes to support P. vivax culture; (2) the optimization of culture conditions in a bespoke bioreactor using
iterative machine learning approaches; and (3) the use of diverse P. vivax parasites. In the R33 period, we will
develop genetic methods for P. vivax, and use these to conduct a genetic screen to understand and overcome
the restriction of P. vivax to reticulocytes.
01/09/2024

Public health relevance
Project Narrative Studies on malaria caused by the parasite Plasmodium vivax would greatly benefit from continuous culture of the pathogen in infected red blood cells. We will use a combination of optimizing red blood cell production, culture medium, and control of the environment using a custom-made bioreactor, all together to achieve continuous culture. Once continuous culture is established, we will develop genetic tools for P. vivax to further enhance its ability to proliferate in red blood cells. 01/09/2024